EFFECT OF CARDIAC DISEASE ON WOMEN'S VOCATIONAL STATUS

Study Objective: Cardiovascular disease is the leading cause of death and disability among women. Nevertheless, little research has been done on the recovery and quality of life of women with this disease. Preliminary research has shown that a woman's employment status is a significant predictor of her quality of life after myocardial infarction. Traditional definitions of employment may not be helpful in this population, however, and other measures may be more meaningful to describe a woman's return to prior functional capacity. Therefore, this study will qualitatively describe the effect of cardiac disease on women's vocational status. Methods: Twenty subjects have participated in a guided, audiotaped interview about the effects of the diagnosis of cardiac disease on their vocational status. Interview transcriptions were analyzed by computer using the constant comparative technique to generate common themes. Summary of Findings: The themes of activity, job satisfaction, support systems, and adjustment of views suggest that vocational status and functional capacity are closely related and that women adjust their view of life satisfaction based on their cardiac event and available support systems.